Development of Optical Imaging/IVUS-Guided Micropuncture System for TIPS Creation

In 2017, decompensated cirrhosis caused more than 1.32 million deaths globally and 62,943 deaths in the
USA. A transjugular intrahepatic portosystemic shunt (TIPS), an intraparenchymal artificial shunt created
between the hepatic vein (HV) and the portal vein (PV), is the most effective life-saving procedure to stop
acute variceal bleeding (AVB) that cannot be controlled endoscopically. TIPS is also effective to decrease the
risk of recurrence of tense ascites and improve renal dysfunction in patients with chronic liver disease.
However, Intrahepatic puncture for TIPS creation remains one of the most challenging and radiation-intensive
procedure, carrying high risks of various complications in up to 20% of cases even in the hands of experienced
Interventional Radiologists. Intraperitoneal hemorrhage caused by liver and extrahepatic portal vein rupture
is the most catastrophic major complication of TIPS creation. In children, TIPS has been employed to alleviate
symptoms of refractory ascites and variceal bleeding, but only adult TIPS puncture sets are available for kids
with portal hypertension. The intrahepatic puncture devices, complications and technical failure rate have not
changed since TIPS was invented by interventional radiologists (IR). To address the critical issues described
above, we are developing a novel in-plane IVUS/fiber optic imaging-integrated micro puncture balloon
catheter system for TIPS creation. Tests of the fine needle/balloon catheter system in pig cadavers for TIPS
creation resulted in 100% success of placing a 5Fr. catheter in the portal vein from the right hepatic vein. This
novel fine needle(22G)/balloon catheter system is expected to eliminate the risk and significantly lower the
difficulties of TIPS techniques, which will ultimately increase the availability of TIPS treatment. The in-plane
IVUS and/or fiber optic imaging guidance will further facilitate TIPS creation. Therefore, we need to implement
a series of experiments to bridge the gap between our laboratory innovation of a novel system for TIPS
creation and clinical translation for treating patients with portal hypertension. At first, we will optimize the key
components and parameters of the needle/balloon catheter systems using human excised cirrhotic liver
specimens. Secondly, we will develop the technique of using fiber optic imaging and/or in-plane IVUS-
integrated needle/balloon catheter system for TIPS creation in normal adult pigs, optimize the technical
parameters, and further validate the technique of using the system for TIPS in pigs with liver cirrhosis and
portal hypertension. At last, we will develop the technique of using this novel system for TIPS creation in baby
and young pigs, optimize the technical parameters, and further validate the technique of using the system for
TIPS in young pigs with portal hypertension. We are confident that the success of this project will lead to
significant breakthroughs in the procedure of TIPS creation and benefit millions of patients with
decompensated cirrhosis.

Public health relevance
PROJECT NARRATIVE Our goal is to develop a novel in-plane IVUS/fiber optic imaging-integrated fine needle/ balloon catheter system for TIPS creation. Tests of the fine needle/balloon system in pig cadavers for TIPS creation resulted in 100% success of placing a 5Fr.catheter in portal vein from the right hepatic vein. This IVUS/fiber optic borescope-incorporated fine needle(22G)/balloon catheter system is expected to significantly lower the risk and difficulties of TIPS techniques, which will ultimately increase the availability of TIPS treatment and benefit millions of patients with decompensated cirrhosis, particularly those in underdeveloped countries.